Association Study of Orofacial Cleft Risk Variants across All of Us Cancer Diagnoses

ABSTRACT
This new grant is a Revision/Administrative Supplement to parent grant R03-DE032062. It has long been noted
that individuals with orofacial clefts (OFCs) and their unaffected relatives have a higher risk of certain
cancers. The hypothesis of this revision is that the association between OFC and cancer is in part due to
genetic commonalities. In this Revision, we will investigate possible associations between OFC genetic risk
variants with the cancer diagnoses in All of Us.

Public health relevance
NARRATIVE In this Revision/Administrative Supplement to parent grant R03-DE032062, we will investigate possible associations between orofacial cleft genetic risk variants and the cancer diagnoses in All of Us.